Regulation of the pro-fibrotic connective tissue growth factor in alcoholic liver disease: mechanisms and targeting approaches

Project Summary / Abstract:
Alcoholic liver disease is a major health and financial concern worldwide. Liver fibrosis and its advanced form,
cirrhosis, can occur in virtually all types of chronic liver disease (CLD) including alcohol-induced liver injury.
According to the American Liver Foundation, 5.5 million Americans are currently afflicted with CLD or cirrhosis,
and the National Institutes of Health (NIH) reports cirrhosis as the 12th leading cause of death due to disease
in America. Hepatic progenitor cells (HPCs) are the source of an alternative regenerative mechanism when
hepatocyte proliferation is inhibited due to severe liver damage. HPC are closely associated with activated
myofibroblast cells (MF) and correlate with severity of liver fibrosis in many CLD. No FDA approved treatment
is currently available for any fibrotic disorder. There is an urgent need for the development of anti-fibrotic drugs
to control progression of fibrosis while in reversible stages.
Connective tissue growth factor (Ctgf) is a profibrotic mediator and modulates cell-cell and cell-matrix
signaling through binding to a variety of growth factors, matrix protein, and cell surface proteins including
integrins. It is a target gene of the transcriptional coactivator Yes-associated protein (Yap) and acts as an
enhancer of transforming growth factor (Tgf)-β, promoting liver fibrosis and HPC activation in chronic liver
disease. Our studies demonstrated fine-tuned regulation of Ctgf via hepatocyte nuclear factor (Hnf)4α
antagonism of Yap and TGF-β1 signaling in regenerating hepatocytes whereas Ctgf deficiency reduces
hepatic inflammation, hepatocyte proliferation and collagen synthesis. Adamts7 (a disintegrin and
metalloproteinase with thrombospondin type I repeat 7) was identified as a novel enzyme for Ctgf turnover
during liver injury. The Ctgf binding protein-extracellular matrix protein (ECM)1- was identified to inhibit Tgf-β
activation and exhibited anti-fibrotic potential. The multifaceted regulations of Ctgf during fibrosis offers
important translational opportunities for diagnosis and follow-up of hepatic fibrogenesis as well as intriguing
targets for therapeutic interventions. Utilizing a noninvasive imaging technique we recently developed, in Aim
1, the function of Adamts7 in regulating fibrotic responses during alcohol-induced liver injury will be examined.
In Aim 2, the anti-fibrotic effects of ECM1 on alcoholic liver injury and HPC activation will be assessed.
This study will provide new mechanistic insights during alcoholic liver disease. The knowledge we
obtain will help identify molecular targets to enhance liver regeneration and reduce liver fibrosis.

Public health relevance
Narrative: Liver fibrosis is a highly conserved response to hepatic tissue injury. Cirrhosis arises as the common final outcome of uncontrolled fibrotic response, ultimately leading to disrupted hepatic architecture, portal hypertension and end-stage liver disease. Alcoholic liver disease (ALD) is a significant cause of morbidity and mortality worldwide. The studies proposed within this application are designed to explore the CTGF/ADAMTS7 or CTGF/ECM1 axes as systems that regulate repair of the liver and its involvement in alcoholic fibrosis and hepatic progenitor cell activation. The overall goal of this proposal is to understand mechanisms underlying liver repair and to develop novel therapies that would prevent or reverse alcoholic fibrosis.